The role of SMAD3 in gene networks underlying human brain activity

Although brain oscillations are a promising target for neuromodulation for cognitive disease, we have a poor
understanding of the molecular mechanisms that lead to oscillatory activity. Motivated by this gap in knowledge,
the Lega-Konopka collaboration has developed groundbreaking techniques to study the links between gene
expression and memory-enhanced brain oscillations. By integrating gene expression data and memory-relevant
iEEG signatures of the same human epilepsy patients, the collaboration discovered significant associations
between memory-associated oscillations and specific gene expression patterns in the temporal pole. This work
identified SMAD3 as a highly promising candidate for future study. We found strong links between SMAD3 gene
expression and slow theta oscillations, which are uniquely important for human cognitive processes. We also
found evidence that SMAD3 binds the regulatory elements of dozens of other genes connected with slow theta
oscillations. Many of these putative SMAD3 gene targets are implicated in neuropsychiatric disorders
characterized by cognitive dysfunction. Taken together, this evidence suggests that SMAD3 may coordinate the
transcription of many genes that affect brain activity during memory processing. However, the brain-specific
transcriptional targets of SMAD3 and the precise impact of SMAD3-mediated gene networks on human neural
activity have yet to be definitively identified. The few studies on the functional role of SMAD3 in the brain showed
that Smad3 knockout mice have impaired neurogenesis and long-term potentiation. Although animal models
generate valuable insight into brain function, the complicated nature of human cognitive processes and related
oscillations decreases the translational value of approaches using animals. To overcome these problems, I will
use human organotypic slice culture (OSC) to define the function of SMAD3 in the regulation of memory-related
gene networks and neural activity in the human brain. In Aim 1, I will enhance SMAD3 activity in human OSC
then use snRNA-seq and snATAC-seq to identify SMAD3 gene targets. In Aim 2, I will demonstrate the ability to
silence SMAD3 expression in human OSC using lentiviral shRNA constructs. I will then use high-density
microelectrode array recordings to understand how the loss of SMAD3 impacts activity at the single neuron and
network levels. By increasing our understanding of the mechanisms underlying memory-relevant brain activity,
the completion of this project will lead us toward new therapies for cognitive disorders. This would be impossible
without the stellar support of Drs. Lega and Konopka, who have expertly guided my development as an aspiring
physician-scientist. The training plan in place for this fellowship period will allow me to learn and develop
innovative skills for studying human brain tissue in vitro with a combination of electrophysiology, molecular
biology, and genomic approaches. Benefitting from the unique combination of expertise from my mentors and
the resources provided by UTSW, this training will allow me to grow as a rigorous, passionate physician-scientist
with the tools to develop novel methods to study and treat the neurological disorders of my patients.

Public health relevance
Brain oscillations and the genes associated with them are promising but poorly understood targets for future neuromodulatory therapies for cognitive disorders like Alzheimer’s disease. SMAD3 expression is associated with memory-enhanced oscillations and gene expression, but it is unknown exactly how SMAD3 influences cognitive processes in the brain. By silencing SMAD3 in human brain tissue in vitro, then characterizing how SMAD3-controlled gene networks influence synchronized neural activity in the same tissue, this project will make major progress toward the ultimate goal of developing neurotherapeutics for cognitive dysfunction.